Tumor targeted drug delivery nanoplatform to overcome therapy resistance glioblastoma

Glioblastoma multiforme (GBM) is associated with poor prognosis due to its highly invasive and drug-resistant
phenotype. Recurrence is a common phenomenon in GBM patients due to the presence of chemo- and radio-
resistant Brain Tumor-Initiating Cells (BTICs). Consequently, current therapies including surgery followed by
radiation or chemotherapy with Temozolomide (TMZ) failed to improve patient median overall survival
emphasizing the necessity of novel treatment strategies for drug-resistant GBM. Interestingly, Neuroplin-1
(NRP1) has been shown to be implicated in the drug-resistance and stemness in multiple types of cancer.
Recently, we showed that depletion of NRP1 improved survival compared to that of vascular endothelial growth
factor (VEGF-A) depletion in mice bearing patient-derived GBM xenografts. NRP1 depletion also improved
sensitivity to TMZ and enhanced the overall survival when combined with TMZ. Our preliminary data further
showed that a proprietary tumor-targeted liposomal (TTL) formulation combining a first generation small-
molecule NRP1 inhibitor (EG00229; G in short) with Everolimus (E) provided significant survival advantage in
TMZ resistant glioma cells as compared to that of TMZ alone. However, EG00229 is poorly water soluble, and
its liposomal formulation is not stable for long term storage. Hence, we developed a new generation of small-
molecule NRP1 inhibitors (NRP1i, Ni in short) with better solubility in order to create a stable liposomal
formulation. The central hypothesis of our proposal is that NRP1i combined with everolimus in a single payload
using TTL, either as a systemic therapy or delivered locally in a hydrogel-based system, will reduce drug-
resistance and stemness and augment radiation sensitivity in GBM, leading to better therapeutic outcomes. To
validate our hypothesis, we propose three major aims. In Aim 1, we will combine the most effective NRP1i with
everolimus as a single payload in TTL formulation (TTL-ENi) for evaluating in vitro efficacy in inhibiting stemness
and drug-resistance signaling pathways and in vivo studies using multiple therapy resistance BTICs animal
models including immune-competent mice models. Further, the additive effect of radiotherapy and chemotherapy
(e.g. TMZ) in combination with the TTL-ENi will be evaluated. We will also analyze the effect of our proposed
therapy on the tumor immune microenvironment using two state-of-the-art techniques namely mass cytometry
(CyTOF) and digital spatial profiling (DSP). In Aim 2, we will assess the efficacy of the local administration of
TTL-ENi-hydrogel in a resection and recurrence model of GBM. Moreover, the additive effect of radiotherapy
and chemotherapy (e.g. TMZ) in combination with the TTL-ENi-hydrogel will be evaluated. Aim 3 will focus on
the comparative pharmacokinetics, pharmacodynamics, and preliminary toxicity studies of the most potent
formulation for future clinical trials. We expect that a successful execution of our proposed research will lead to
clinical trial in near future for a better therapeutic strategy to override the drug-resistance in GBM patients as
well as patients suffering from other drug-resistant cancers.

Public health relevance
This proposal aims to evaluate the translational potential of a proprietary tumor-targeted liposomal (TTL) formulation combining a new generation of neuropilin-1 inhibitor having better efficacy and pharmacokinetic parameters and everolimus in a single payload, via preclinical evaluation in multiple relevant mouse models of Glioblastoma Multiforme (GBM). Additionally, a local administration of the liposomes entrapped in a hydrogel system will be compared with systemic administration of the liposomes in an established resection model where the primary tumor will be taken out by surgery before initiating treatment. The most effective formulation will be used for pharmacokinetic and preliminary toxicity studies as a stepping stone for future IND application and potential clinical trials seeking to benefit GBM patients as well as patients suffering from other types of drug-resistant cancer.